Planning and Evaluation Core (PEC)

PLANNING AND EVALUATION CORE
PROJECT SUMMARY/ABSTRACT
The Planning and Evaluation Core (PEC) serves as a facilitative resource to provide oversight and data
support in the development, implementation, coordination, and management of all Partnership activities
for the Partnership's Infection-Driven Malignancies Program for Advancing Careers and Translational
Sciences (IMPACT). This core, which works collaboratively with the Administrative and DATAOmics
Cores, provides assistance with the daily activities of the Partnership, including, but not limited to, data
collection, data evaluation, and meeting planning, as well as to spearhead short-term and long-term
strategic planning and prioritization for the successful achievement of Partnership initiatives. The PEC is
composed of an Evaluation Team (ET), the Internal Advisory Committee (IAC) and the Program Steering
Committee (PSC). Through these three components, the PEC conducts via a continuous process, the
planning and evaluation of all partnership activities. Specific Aims for the PEC include: 1) Provide
continuous support to cores and research projects to incorporate evaluation tools and approaches in order
to document Partnership's progress and accomplishments; 2) Promote an evaluation culture supported
through a rigorous internal reviewing process in order to continuously improve Partnership performance
and maximize resources; and 3) Support a critical external assessment process of the Partnership in order
to enhance its performance, provide recommendations for improvements and inform new directions.